Project 2 - Epigenetic Drivers of Lineage Plasticity in Lung Cancer

PROJECT SUMMARY (Project 2)
Lung cancer remains the leading cause of cancer death worldwide and can be divided into distinct
histological subtypes including lung adenocarcinoma (LUAD) and small cell lung cancer (SCLC). Lineage
plasticity is an emerging mechanism of resistance to targeted therapies in lung cancer, yet the mechanisms that
drive this are largely unknown. It is thus fundamentally important to understand how SCLC/LUAD lineage
plasticity is regulated within the autochthonous lung tumor immune microenvironment.
To study the role of the epigenetic modifier EED in SCLC tumorigenesis, we used a CRISPR/Cas9-based
approach to develop SCLC genetically engineered mouse models (GEMMs), where EED was simultaneously
inactivated at tumor initiation in the lung. Strikingly, EED deletion results in complete histological transformation
from SCLC to LUAD in nearly all mice, with only a small percentage of mice retaining some degree of SCLC
histology. Moreover, EED inactivation in SCLC cell lines in vitro was not sufficient to induce complete SCLC to
LUAD lineage plasticity, suggesting that non-cell autonomous mechanisms contribute to this phenotype in vivo.
Based on these data, we hypothesize that SCLC to LUAD histological transformation after EED inactivation
requires both tumor cell intrinsic de-repression of EED target genes and selection by tumor cell extrinsic
mechanisms. Specifically, we hypothesize that EED normally binds and directly represses key LUAD lineage
oncogenes, and that EED inactivation primes for SCLC to LUAD lineage plasticity by de-repressing these key
LUAD lineage oncogenes. We will interrogate this hypothesis in aim 1 by combining ChIP-seq, RNA-seq, and
functional genomics experiments, aided by the deep expertise in these methods and analyses of our wider P01
team. Since de-repression of this epigenetic program alone is not sufficient for full SCLC to LUAD histological
transformation, we hypothesize that full histological transformation requires further selection by extrinsic stimuli
from the tumor microenvironment (TME). We hypothesize that the TME provides ligands to stimulate receptor
tyrosine kinases that drive LUAD oncogenic signaling. Moreover, EED inactivation promotes MHC-I antigen
presentation that normally causes immunological rejection and thus we also hypothesize that LUAD lineage
oncogenic signaling creates an immunosuppressive TME that permits the development of LUAD in the presence
of restored MHC-I antigen presentation after EED inactivation. We will test whether growth factor ligands from
the TME and restored tumor cell MHC-I help drive SCLC to LUAD lineage plasticity in aim 2.
Together, these studies will deeply dissect how EED restricts the SCLC lung cancer lineage in the contexture
of the native tumor immune microenvironment and could inform new therapeutic strategies to intercept this
treatment refractory resistance mechanism in lung and other cancer types.

Public health relevance
PROJECT NARRATIVE The goal of our proposed research is to identify mechanisms that regulate small cell lung cancer to lung adenocarcinoma lineage plasticity. Through these studies, we will enhance our fundamental understanding of the epigenetic drivers that determine lung cancer histology. These studies have the potential to identify new tractable therapeutic strategies to prevent the development of lineage plasticity as a mechanism of therapeutic resistance to targeted therapies in lung cancer.